TWO PHOTON FLUORESCENCE EXCITATION IN CONTINUOUS WAVE IR OPTICAL TWEEZERS

We report the observation of two-photon fluorescence excitation in continuous wave (CW) single beam gradient force optical trap and demonstrate its use as an in situ probe to study the physiological state of an optically confined sample. In particular, a cw Nd:YAG (1064-nm) laser is used simultaneously to confine, and excite visible fluorescence from submicrometerregions of, cell specimens. Two-photon fluorescence emission spectra are presented for motile human sperm cells and immotile Chinese hamster ovary cells that have been labeledwith nucleic acid and pH-sensitive fluorescent probes. The resulting spectra are correlated to ligh-induced changes in the physiological state experienced by the trapped cells. This spectral technique should prove extremely useful for monitoring cellular activity and the effects of confinement by optical tweezers.